Administrative Core

ABSTRACT
The Administrative Core will coordinate the administrative, fiscal, and organizational aspects of this P01 program.
This is a complex and highly interactive program, involving investigators from several institutions, and including
work in non-human primate models. To ensure success, the Program has been established with joint Principal
Investigators, Drs. Paula Cannon (USC) and Hans-Peter Kiem (FHCC). Dr. Cannon will serve as the NIH primary
contact and will oversee all financial interactions and sub-contracts. Both Dr. Cannon and Dr. Kiem will be
assisted by local administrative support to facilitate the lines of communication between the co-PIs, and within
the broader Program. The overall goals of the Administrative Core are: (1) To provide intellectual leadership and
guidance for the scientific investigations and collaborations occurring within the Program Project; (2) To provide
administrative, fiscal, and scientific review procedures to ensure that the P01 functions effectively; and (3) To
facilitate communications and data dissemination between the P01 investigators.